Food Protection Task Force Conference

Indiana Food Safety and Defense Task Force Summary The Indiana Food Safety and Defense Task Force formed to foster partnerships among industry, academia, and governmental agencies. There are The task force consists of 112 members from State/local government, industry, and academia and 14 Federal participants (non-members). These relationships are further developed and strengthened through the bi-annual Task Force meetings. The meetings feature numerous speakers from industry and government discussing various food safety and defense topics. The meetings are very successful and demonstrate that industry is responding to food safety and defense threats and partnering with government to keep the food supply safe and secure. The Task Force received grant funding from FDA that allows the membership to hold two training meetings per year for information sharing, training, and discussing current issues and concerns. Over the past few months the Task Force has been leveraging new technology and has established the Indiana Food Safety and Defense Task Force Workgroup on FoodSHIELD to share information among the various members and participants. The membership received training on the FoodSHIELD system at the last meeting on March 17, 2010, and has already started sharing documents and discussing issues in the secure workspace on the system.

Public health relevance
Project Narrative The Indiana State Department of Health (ISDH) provides the staff support for the Indiana Food Safety and Defense Task Force. Grant funds have allowed the Task Force to expand the scope of work to focus on food safety and food defense issues to further protect Indiana's vital food and agriculture infrastructure. The task force consists of 112 members from State/local government, industry, and academia and 14 Federal participants (non- members). The Indiana Food Safety and Defense Task Force is currently structured to meet two times per year. Regular meetings are held during March and November of each year. Task Force meetings are structured to begin at 8 a.m. and end at 4 p.m. Each meeting is set up with approximately six speakers to provide relevant food safety and defense information. Time is also provided for roundtable discussions between government, industry, and academia on current issues and concerns. __SpecificAimsTextDelimiter__ Indiana Food Safety and Defense Task Force- Project Narrative The Indiana State Department of Health (ISDH) provides the staff support for the Indiana Food Safety and Defense Task Force. This Task Force was formerly known as the Indiana Food Security and Bioterrorism Preparedness Task Force and has been meeting since 2003. Grant funds have allowed the Task Force to expand the scope of work to focus on food safety and food defense issues to further protect Indiana’s vital food and agriculture infrastructure. The task force consists of 112 members from State/local government, industry, and academia and 14 Federal participants (non-members). * Provide a forum for open dialogue between the industry, regulators, academia and other stakeholders, who have an interest in food safety and defense¿ brings key individuals together * Provides opportunity to gain valuable technical expertise to work on special projects identified by the Task Force or other groups * Provides an opportunity for the stakeholders to have input on proposed or future rules, regulations and statutes * Provides opportunities for stakeholders to provide insight when regulators are developing formal guidance policies, such as the ISDH Food Emergency Response Plan and the Value-added Foods Guidance * Promotes an educational, rather than an adversarial, environment for the stakeholders, thereby dissolving barriers * Identifies and develops topics for future educational/training meetings * Promotes understanding of issues by all sides and fosters communication during the meetings and outside the meetings * As outlined in the grant guidance one of the task force objectives will be to promote the integration of an efficient statewide food safety and defense system that maximizes the protection of the public health through the prevention, early detection and containment of food-borne illness * Promotes a safer food supply while enhancing economic development * Become a recognized consortium of key groups that can offer opinions to other groups, such as the IN General Assembly, IN Department of Homeland Security, IN Department of Agriculture, etc. * Focuses on Food Defense, Prevention, Intervention, and Response by arranging speakers to address these topics at the bi-annual meetings * Leverages new technology for sharing information and training by utilizing the Indiana Food Safety and Defense Task Force Workgroup features on the FoodSHIELD web-based system. The Indiana Food Safety and Defense Task Force is currently structured to meet two times per year. Regular meetings are held during March and November of each year. Recent Task Force meetings have been held at the Holiday Inn North in Indianapolis, which is a central location with easy access for the Task Force members. Task Force meetings are structured to begin at 8 a.m. and end at 4 p.m. Each meeting is set up with approximately six speakers to provide relevant food safety and defense information. Time is also provided for roundtable discussions between government, industry, and academia on current issues and concerns.